Impact of Obesity on Immuno-Oncology Agents in Endometrial Cancer

PROJECT SUMMARY
Obesity is associated with increased risk of developing and succumbing to endometrial cancer (EC), with ~60%
of EC patients being obese. Since programmed death protein-1 (PD-1) and its ligand, programmed death-ligand
1 (PD-L1), are highly expressed in ECs, immuno-oncologic inhibitors for these two targets hold great promise
for the treatment of obesity-driven EC, especially as ~25% of ECs have microsatellite instability, a known
biomarker for PD-1/PD-L1 inhibitor response. Atezolizumab is one such anti-PD-L1 monoclonal antibody (mAb).
Our studies suggest the obesity-triggered pro-inflammatory uterine tumor milieu increases PD-L1/2, culminating
in enhanced susceptibility to atezolizumab. The efficacy of atezolizumab in EC may be enhanced via ONC201,
a small molecular selective dopamine receptor 2 antagonist that upregulates Tumor Necrosis Factor-Related
Apoptosis-Inducing Ligand and activates T and natural killer (NK) cells. Thus, ONC201 is a logical therapeutic
partner for atezolizumab.
However, the use of atezolizumab + ONC201 in EC is complicated by obesity. Compared to small molecule
drugs, mAbs are cleared via cells of the mononuclear phagocyte system (MPS; monocytes) which is part of the
innate immune system. MPS cells serve as a natural mechanism of uptake and clearance for mAbs via their Fc-
gamma-receptors (FcɣRs). Our studies show MPS mediators, number of FcɣRs and function in blood are highly
variable and associated with the high and clinically relevant variability in the
pharmacokinetics/pharmacodynamics (PK/PD) of mAbs. Obese patients have higher and more variable MPS
mediators, FcɣRs and function, resulting in lower exposures of mAbs. Thus, evaluating effects of obesity on the
PK/PD of atezolizumab and ONC201 in EC patients is clinically relevant and critically important. Our hypothesis
is that atezolizumab + ONC201 will be safe in EC; however, despite obese EC patients having higher expression
of PD-L1 and a pro-inflammatory tumor milieu, they will have lower atezolizumab plasma levels, than the non-
obese at the same dose due to increased phagocytic clearance, necessitating higher dosing in the obese to
achieve serum levels comparable to those of the non-obese patients.
We propose a phase 1 clinical trial of the novel combination of atezolizumab + ONC201 using an innovative
design of parallel cohorts of obese and non-obese patients with metastatic and recurrent EC. Our primary
objective is to evaluate the safety and tolerability of the dual regimen of atezolizumab and ONC201 in obese and
non-obese EC patients to find the maximal tolerable dose combination to then advance for both cohorts in a
future phase 2 study. In order to comprehensively delineate the impact of obesity on the combination of
atezolizumab + ONC201, we will compare between the obese and non-obese EC groups the PK/PD of both
agents, biomarkers reflective of the immune-oncology and of the MPS clearance of both agents, and their
inflammatory metabolic signatures.

Public health relevance
PROJECT NARRATIVE Obesity is associated with increased risk of developing and succumbing to endometrial cancer (EC), with ~60% of EC patients being obese. We hypothesize that gyn-onocologists may be under-dosing obese EC patients treated with monoclonal antibodies (mAbs), such as atezolizumab, inadvertently decreasing their potential treatment efficacy in this obesity-modulated cancer, due to differences in the mononuclear phagocyte system (MPS) between obese and non-obese women. Thus, our goals are 1) to establish in this phase 1 trial the pharmacokinetics/pharmacodynamics (PK/PD) and the safe maximum tolerated dose (MTD) of atezolizumab + ONC201 in combination as an innovative promising treatment for EC, with expectation that higher dosing of atezolizumab will be required for obese women; 2) use the results and MTDs of these phase 1 trials to design future phase 2 clinical trials; and 3) create new biomarkers and strategies to individualize therapy of this unique atezolizumab/ONC201 combination that could be expanded in application to other immuno-oncology agents used to treat obese patients with EC or other cancer types.